The Effect of Subnuclear Compartmentalization on DNA Double-Strand Break Repair

Project Summary/Abstract
DNA double-stranded breaks (DSBs) represent a danger to genome stability. Cells can repair DSBs through
non-homologous end-joining (NHEJ) or homologous recombination (HR). Repair pathway choice is critical
because failure to choose the most faithful repair mechanism can lead to cancer. NHEJ is the direct ligation of
the DSB ends, and as such it does not involve any repair templates. It is rapid, but error prone. In contrast, HR
is the more faithful repair pathway that uses the sister chromatid as a template for repair and therefore is
upregulated in S/G2 phases of the cell cycle. HR is initiated by the end resection of the DSB (creating 3’ single-
stranded overhangs). It then proceeds with the loading of repair proteins, most importantly RAD51, onto the
resulting ssDNA to allow the broken chromosome to strand invade a homologous template (ideally the sister
chromatid). New synthesis and resolution complete homology-dependent repair. My project focuses on how
HR is regulated post-resection, especially on how the recruitment of recombination factors is regulated in time
and space. Previous work has shown that nuclear compartmentalization plays a role in regulating the loading
of repair factors onto resected ssDNA through a mechanism involving RNA-DNA hybrids. Loading of repair
factors is different in the two nuclear compartments: the euchromatic nuclear interior and the heterochromatic
nuclear periphery. Specifically, in the nuclear interior, Rad52, which remodels RPA to Rad51 loading in yeast,
is efficiently recruited to resected DSBs and is retained there during repair. By contrast, in DSBs tethered to
the nuclear periphery, Rad52 loading is highly transient. My preliminary data suggest that Rad52 loading is
antagonized at the nuclear periphery by hybridization of RNA with the resected ssDNA. Accordingly, reducing
RNA/DNA hybrids by over-expression of RNase H partially restores Rad52 loading in DSBs at the nuclear
periphery. This suggests a competitive mechanism between RNA-DNA hybrids and loading of pro-HR factors
onto resected ssDNA at a DSB specifically at the nuclear periphery. My goal is to identify the source of the
relevant RNAs, how they are processed, and how they affect DSB repair. My approach is to use a genetic
model to investigate the loading of small RNAs onto resected ssDNA at asite-specific, inducible double-
stranded break (DSB). I plan to use live-cell imaging, quantitative PCR, genetic perturbations, small RNA
sequencing, and detection of RNA-DNA hybrids by DNA immunoprecipitation (DRIP using the S9.6 antibody).
Further, I will use a previously designed imaging assay to observe the timing of Rad52 loading and resection
progression in single cells and genetic repair outcome assays. For each of these approaches, I will use fission
yeast strains that are genetically engineered to tether the DSB to the nuclear periphery and to overexpress
RNase H2 (to degrade RNA-DNA hybrids). These results will shed light on the relationship between nuclear
compartments and DNA repair mechanisms and efficiency, providing new insight into genome integrity.

Public health relevance
Project Narrative Errors in DNA repair can lead to diseases, such as cancer. There is much known about various DNA repair pathways, but not much is known about how they are regulated. This project seeks to understand how DNA repair is regulated in the context of nuclear compartments, helping us understand how these diseases arise.